Actin promotes ciliary motility in Tetrahymena thermophila

PROJECT SUMMARY
Motile cilia generate fluid flow in organisms ranging from microbes to humans. Defective ciliary function can
produce severe pathologies, including infertility, severe respiratory infection, and hydrocephaly. Motile cilia
beat in a coordinated fashion to effectively move fluids across cell surfaces. While the role for the microtubule
cytoskeleton and dynein activity is well characterized for undulating cilia, the mechanics for how hundreds of
cilia in multiciliary arrays beat in a coordinated and connected array remains a significant gap in the field.
One critical feature of coordinated ciliary motility is the spatial organization of cilia. The position of cilia is
precisely patterned at the cortex by basal bodies (BBs), which are microtubule-based structures that nucleate
cilia. BBs anchor to the cell cortex through three BB-appendage structures that asymmetrically extend from
BBs. BB-appendages function in maintaining BB organization, as these structures physically bridge
neighboring BBs to each other and to the cell cortex. The coupling of BBs together and to the cortex creates a
structured matrix to dissipate the forces generated by ciliary beating and to translate such forces to the cell.
This is most evident by the finding that loss of cortical actin leads to beating cilia being ripped from the cell
cortex. However, how cortical actin anchors BBs to the cell cortex in multiciliated cells has yet to be
determined.
The ciliate model organism Tetrahymena thermophila is an excellent system to address these gaps in
knowledge. These cells have well-characterized BB-appendage connections between neighboring BBs, and
between BBs and the cell cortex allowing us to elucidate the role for actin in BB anchoring and BB organization
in promoting coordinated ciliary motility. Furthermore, Tetrahymena actin localizes to BBs and cilia, where
roles for actin in ciliary beating or coordinated waveforms have yet to be established. Thus, the role of ciliary
and cortical localized actin will be elucidated using Tetrahymena. An important aspect of this proposal is to
uncover the basic components of these actin networks to begin to understand their differential regulation and
contributions to ciliary motility. In addition, the existing ultrastructural understanding of BBs, BB-appendages,
cortical contacts and ciliary axonemes provides a foundation for examining actin's requirement for structural
integrity and localization within these structures.
In this proposal, the role for actin that localizes to cilia and the cell cortex will be determined in promoting
coordinated and efficient ciliary motility by utilizing molecular-genetic, cell biological and ultrastructural
approaches. These goals will be accomplished according to my detailed research plan, by the exceptional
qualifications of Dr. Pearson, my postdoctoral advisory committee and utilizing the facilities and training
resources available at the University of Colorado, Anschutz Medical Campus.

Public health relevance
PROJECT NARRATIVE Multiciliary arrays are essential for species from microbes to humans to efficiently move fluids across cell surfaces or epithelial barriers, as disruption of motile cilia in humans causes severe pathologies, including infertility, severe respiratory infection, and hydrocephaly. The fundamental mechanics for how cilia undulate in a coordinated and polarized fashion within multiciliary arrays are poorly understood. The proposed work aims to understand how the actin cytoskeleton coordinates with the fundamental proteins required for ciliary beating in multiciliary arrays.